C3-Dependent Intracellular Killing in Innate Immunity and Bacterial Pathogenesis

SUMMARY
Bacterial infections remain a leading cause of morbidity and mortality worldwide and a critical public health issue
due to increasing antibiotic resistance and limited vaccines. Many of the most consequential bacterial infections
originate at mucosal surfaces, such as the gut, respiratory tract or skin, then disseminate to other tissues via the
bloodstream. Two preeminent human pathogens causing both mucosal and invasive diseases are Gram-
negative Salmonella enterica (e.g., serovar Typhimurium, STm) and Gram-positive group A Streptococcus
(GAS). Pivotal to innate host defense against bloodstream infection is the function of complement system
proteins and their activation cascades, especially opsonization by C3, coupled with the bactericidal activity of
phagocytic cells including macrophages (MΦ) and neutrophils. Pathogenic strains of STm and GAS can subvert
phagolysosome function to survive intracellularly in MΦ ex vivo and in vivo, whereupon the autophagy system
emerges as a critical battleground for pathogen survival/killing. This project brings together two highly
experienced and productive physician-scientist investigators with complementary expertise: Gram-negative
bacterial pathogenesis, mucosal immunity and gnotobiotic mouse models (MPI, M. Raffatellu) coupled to Gram-
positive bacterial pathogenesis, innate immunity, and bacterial-phagocyte interactions (MPI, V. Nizet). Together
we have recently discovered a novel, essential intracellular function of C3: targeting of bacteria to the autophagy
system for killing in MΦ – a discovery that may challenge conclusions of countless studies of MΦ-bacterial
interactions performed in the absence of active serum. Further, we have discovered that the STm serine protease
PgtE, the GAS serine protease SpyCEP, and the GAS cysteine protease SpeB allow the respective pathogens
to inactivate C3 and to replicate intracellularly in MΦ. Our central hypothesis is that intracellular C3-dependent
autophagy is critical to host innate defense, and that the ability of invasive pathogens such as STm and GAS to
counteract this process substantially increases their disease-causing potential. Recent data also indicate the
microbiome plays an essential role in skin and mucosal complement production, which may represent another
crucial factor by which commensal microbes affect invasive bacterial infection risk. Here we propose to continue
to investigate the role of intracellular C3 during infection, to understand the ramifications of this new principle of
innate immunity on host-pathogen interactions and the outcome of two of the most important human infectious
diseases. Our approaches are likely to reveal new virulence genes and host immune pathways that will connect
mechanisms, resolve longstanding knowledge gaps, and lead to new avenues of investigation of broad relevance
to bacterial pathogenesis including potential novel therapeutic targets and leads.

Public health relevance
Project Narrative Bacterial infections remain a leading cause of morbidity and mortality worldwide and a critical public health issue due to increasing antibiotic resistance and limited vaccines. Here we will investigate the interplay between two prominent human pathogens (Salmonella enterica and group A Streptococcus) and the complement system. This work may lead to new strategies to prevent and treat these infections.